D AMINOACID LIGASES AND BACTERIAL VANCOMYCIN RESISTANCE

DESCRIPTION (Adapted from applicant's abstract): Because of the increased appearance of vancomycin resistance in methicillin-resistant Staphylococcus aureus, and its consequences to hospital patients, it is of vital importance to understand the nature of this resistance and to develop effective inhibitors for treatment of infections. Vancomycin is used as the backup antibiotic for gram-positive infections which do not respond to penicillin therapy and for patients allegeric to penicillin. Four specific aims are proposed: (1) determine x-ray structure of the Leuconostoc mesenteroides D-Ala:D-Lactate ligase, (2) determine the structure of F261Y mutant which exhibits a reversal of substrate specificity to produce D-alanine-D-alanine, (3) to generate a model of VanA, and (4) inhibitor design.